Mechanistic and structural studies of eukaryotic UDP-galactopyranose mutases

DESCRIPTION (provided by applicant): Galactofuranose (Galf) is an important building block of the cell wall of pathogenic fungi and a major component of the cell surface glycoconjugated structures (sugar coat) of protozoan parasites. Because of the importance of Galf-containing molecules for host-specific cell recognition, growth, and pathogenesis, and the absence of this unusual sugar in humans, Galf biosynthetic enzymes are attractive targets for the development of new antimicrobial agents. The flavoenzyme UDP-galactopyranose mutase (UGM) plays a central role in Galf biosynthesis by catalyzing the conversion of UDP-galactopyranose to UDP-Galf. Deletion of the UGM gene results in severely attenuated virulence of the fungal pathogen Aspergillus fumigatus and the protozoan parasite Leishmania major, suggesting UGM as a promising drug design target. In addition, UGM is fundamentally interesting because the enzyme neither oxidizes nor reduces the substrate, which is unusual among flavoenzymes. Studies of bacterial UGMs have shown that the reduced flavin is necessary for catalysis, but the role that the flavin plays during the catalytic cycle remains controversial. Here, we propose the first studies of the catalytic mechanism and three-dimensional structure of eukaryotic UGMs, using the enzymes from A. fumigatus and Trypanosoma cruzi as prototypes from fungal and protozoan parasites, respectively. Key preliminary results include the production of active recombinant enzyme and the growth of preliminary crystals. Two aims are proposed: 1. Determine the role of the flavin cofactor in the chemical mechanism of eukaryotic UGMs. Experiments proposed include rapid reaction kinetic spectroscopic analyses, characterization of the redox potential and pH profiles, testing potential alternative substrates and inhibitors, and identifying redox partners. 2. Determine the three-dimensional structures of eukaryotic UGMs. Structures of UGMs in the oxidized, reduced, and ligand-bound conformations will be solved using X-ray crystallography and small-angle X-ray scattering. Successful completion of these aims will provide a platform for the future design of structure- and mechanism- based inhibitors of UGMs, which could serve as lead compounds for the development of chemotherapeutics for the treatment of fungal infections and neglected diseases such as Chagas disease. )

Public health relevance
PUBLIC HEALTH RELEVANCE: UDP-galactopyranose mutase (UGM) catalyzes a key step in the biosynthesis of galactofuranose (Galf), an essential sugar molecule found in pathogenic fungi and disease-causing protozoan parasites. The proposed research will create new knowledge about the catalytic mechanism and three-dimensional structure of UGM from the fungus Aspergillus fumigatus and the causative agent of Chagas disease, the parasite Trypanosoma cruzi. This information will aid the development of antimicrobial agents targeting these important human pathogens. UDP-galactopyranose mutase (UGM) catalyzes a key step in the biosynthesis of galactofuranose (Galf), an essential sugar molecule found in pathogenic fungi and disease-causing protozoan parasites. The proposed research will create new knowledge about the catalytic mechanism and three-dimensional structure of UGM from the fungus Aspergillus fumigatus and the causative agent of Chagas disease, the parasite Trypanosoma cruzi. This information will aid the development of antimicrobial agents targeting these important human pathogens. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Galactofuranose (Galf) is an important component of the cell wall of bacteria and fungi and is a virulence factor in protozoan parasites. Inhibition of UDP-galactopyranose mutase (UGM), the flavoenzyme that catalyzes the conversion of UDP-galactopyranose (UDP-Galp) to UDP-Galf, prevents growth of Mycobacterium, and deletion of the UGM gene dramatically attenuates virulence of Aspergillus and Leishmania species. Since UGM is not found in humans, inhibition of this enzyme is an attractive strategy for the development of antimicrobial agents (1-3). In addition to its importance as a drug-design target, UGM is also a unique flavoenzyme whose mechanism has not been fully delineated. In contrast to most flavoenzymes, such as flavin oxidoreductases, there is no net redox change in the formation of product. Although it is known that the reduced FAD is required for catalysis, the precise role that the flavin plays in the mechanism remains to be established. The lack of mechanistic and structural information is particularly acute for eukaryotic UGMs, which have not been purified to date. The goal of this project is to provide a detailed description of the chemical mechanism of eukaryotic UGMs using enzymes from the fungus Aspergillus fumigatus (AfUGM) and the parasite Trypanosoma cruzi (TcUGM) as the prototypes for this class of UGMs. Results obtained from the proposed studies will aid the design of inhibitors of UGMs and expand our understanding of the function of this novel flavoenzyme. These outcomes will be achieved through the following specific aims. Aim I: Determine the role of the flavin cofactor in the chemical mechanism of eukaryotic UGMs. We will use rapid reaction kinetic spectroscopic analyses to identify, trap, and characterize intermediates during turnover. The redox potential and pH profiles will be measured to determine the chemical nature of the reactive species. Substrate analogues will be used to probe the chemical mechanism. The activity of several known small molecule inhibitors of bacterial UGMs will be tested against the eukaryotic UGMs. Reduction of the bound FAD, which is necessary for catalysis, will be studied by testing the electron transfer efficiencies of potential redox partners. Results from these experiments will provide essential information regarding the role of the flavin cofactor in this unusual reaction. Aim II: Determine the three-dimensional structures of eukaryotic UGMs. The three- dimensional structures of AfUGM and TcUGM will be determined using X-ray crystallography and small-angle X-ray scattering (SAXS). We will solve the crystal structures of the enzymes in the oxidized and reduced states and in complex with substrate, product, and substrate analogs. The enzymes will also be studied in solution using SAXS to gain information about quaternary structure and conformational changes induced by ligand binding and changes in the flavin redox state. Results from this Aim will complement the mechanistic studies of Aim I and provide crucial information for the future development of inhibitors.